Understanding the Molecular Mechanisms of Neuronal Control in Sweat Gland Development

PROJECT SUMMARY
Eccrine sweat glands are the most abundant gland in our skin and are essential for thermoregulation
and skin homeostasis. It was only recently that multipotent stem cells in the sweat glands were identified,
which presented great potential for de novo sweat gland regeneration. Further, in order to make sweat glands
functional, precise innervation and neuronal control are indispensable. Neuronal signals elicit sweating; but
also, are necessary for sweat gland maturation based on prior work in our lab. Sweat glands and neurons rely
on each other for proper development; however, very little is known about how neuronal inputs influence sweat
gland development, especially the sweat gland stem cells. We hypothesize that neuronal innervation is
critical for the maintenance of sweat gland stem cells during development. Using mouse sweat gland as
a model, we will investigate the molecular changes in the sweat gland stem cells during development when
lacking innervation, and further identify the downstream pathway within sweat gland stem cells that mediates
the effect of neurotransmitters upon stem cell maintenance. This proposal aims to i) investigate the effect of
neuronal input during sweat gland development ii) understand the role of neurotransmitters in sweat gland
development iii) examine whether calcium mediates neuronal control of the sweat gland stem cells. These
studies will provide greater insight into how nerves regulate the development and maintenance of sweat
glands. Further, this proposal will establish a foundational understanding of how sweat glands and neurons
develop into a function unit which will be useful for regenerative therapies.

Public health relevance
PROJECT NARRATIVE Severe burn victims and patients suffering from congenital sweat gland deficiencies are unable to properly maintain body temperature, which can lead to consequences such as hyperthermia, heat stroke, brain damage, and potentially death. Uncovering the molecular mechanisms of neuronal control in sweat gland development will enhance our understanding to regenerate fully functional sweat glands with proper innervation for these patients to restore their sweating ability.